Study the role and origin of hybrid insulin peptides in the pathogenesis of type 1 diabetes

Abstract
Type 1 diabetes (T1D) is caused by an autoimmune response that targets and destroys insulin-producing
beta cells in the pancreas. Despite advancements in managing T1D, identifying specific antigens critical for T1D
onset has been challenging. Recent research has uncovered hybrid insulin peptides (HIPs), which induce an
autoimmune CD4 T cell response and may serve as specific autoantigens in T1D. HIPs are generated when a
peptide fragment of proinsulin binds to a peptide fragment from other beta cell proteins. Presence of various
HIPs has been validated through mass spectrometric analyses of human and murine islet samples. Several of
those identified HIPs have a known CD4 T cell that specifically targets them in human and murine disease. We
consider these HIPs as disease-relevant because we not only have mass spectrometric evidence for their
existence, but also immunological evidence verifying their role in disease. In this proposal, we plan to study the
role of disease-relevant HIPs formed by the enzyme Cathepsin D (CatD) in the progression of diabetes in non-
obese diabetic (NOD) mice, a amahor animal model used for the study of T1D. We hypothesize that a mutation
of an insulin leucine residue (targeted by CatD) can effectively prevent CatD-mediated HIP formation, resulting
in a reduction of disease incidence in genetically modified mice compared to wildtype mice. We will assess HIP
formation by analyzing mouse islet samples using mass spectrometry, confirm HIP content through T cell assays
with HIP-reactive T cell clones, and monitor mice for disease incidence and immune cell infiltration of the
pancreatic islets. The researchers will also investigate the origin of another subgroup of HIPs (identified in human
islets) that do not form through a CatD-mediated process. For this we apply a proteomic strategy to probe human
islet samples by mass spectrometry with the objective to identify the enzyme responsible for their formation. The
results of these experiments will provide a better understanding of the role of HIPs in disease onset. Furthermore,
the identification of additional HIP-forming processes in human islets may lead to the discovery of a new
therapeutic target, that may allow us to selectively block formation of HIPs in beta-cells. The proposed studies
also offer me the opportunity to expand my understanding of several fields including immunology, proteomics,
and mass spectrometry. These combined skillsets will provide me with expertise needed to study numerous
diseases and pathogenic process throughout my anticipated career as independent investigator.

Public health relevance
Project Narrative Type 1 diabetes is an autoimmune condition in which the insulin producing beta cells are selectively targeted for destruction. The specific autoantigens that are critical for disease onset have yet to be identified, however, we have identified autoantigens that may play a significant role in the development of disease. The current proposal aims to determine the origin of these autoantigens and to study if the level of these autoantigens can affect the pathogenesis of type 1 diabetes. Results from these studies may allow us to establish a disease-critical role of the antigens in the pathogenesis of diabetes.